Microbial Community Disruption Following Topical Antimicrobial Application in Staphylococcus aureus-Affected Households

PROJECT SUMMARY
The National Action Plan for Combating Antibiotic-Resistant Bacteria identified critical research needs to
confront the advancing threat of antimicrobial resistance. These include understanding the nature of microbial
communities, determining the effects of antibiotics on these communities, and harnessing these communities to
develop strategies for disease prevention. Staphylococcus aureus causes significant morbidity and mortality in
healthcare and community settings. S. aureus carriage confers risk for endogenous infection. Previous studies
investigated clinical and epidemiological factors associated with S. aureus colonization and infection, although
the influence of the skin and nasal microbiota on S. aureus acquisition is unclear. We hypothesize that features
of the commensal microbiota may confer susceptibility to, or provide protection against, S. aureus acquisition
and development of subsequent infection. Further, in an effort to prevent S. aureus acquisition and infection,
decolonization with topical antimicrobials is frequently employed in healthcare and community settings. However,
broad-spectrum topical antimicrobial application may disrupt commensal microbiota, thereby promoting the
acquisition or enrichment of multidrug-resistant and/or potentially pathogenic microorganisms. The impact of this
potential adverse effect remains understudied.
In this proposed project, we will analyze a vast and unmatched biorepository of >13,000 skin and nasal swab
samples that were longitudinally collected over 24 months from a well-characterized cohort of 476 participants,
including 99 pediatric patients with methicillin-resistant S. aureus skin infections and their household contacts,
all of whom are at high risk for S. aureus acquisition and infection. The samples were collected during 12 months
of longitudinal samplings (the natural history phase) followed by a randomized, 5-day decolonization intervention
with topical antimicrobial application, and subsequent longitudinal sampling for 12 months (post-decolonization
phase). We will perform metagenomic shotgun sequencing (enabling classification at the species and strain
levels), to longitudinally characterize skin and nasal microbial communities in the context of S. aureus
colonization and disease. We will compare microbial community features associated with susceptibility or
resistance to S. aureus acquisition between household contacts with different phenotypic outcomes (e.g.,
colonization and infection), and integrate these data with detailed epidemiological data to predict individuals at
risk for acquiring S. aureus colonization and/or developing symptomatic infection. We will quantify changes in
microbial community structures following topical antimicrobial application, and correlate this disruption with
subsequent acquisition and persistence of S. aureus and other pathogens. Finally, we will employ innovative
targeted sequence capture to quantify genetic determinants of antimicrobial resistance (the “resistome”) in
samples collected before and after decolonization. The essential knowledge generated by this study will optimize
preventive strategies for S. aureus colonization and infection and their targeting to susceptible individuals.

Public health relevance
PROJECT NARRATIVE Infections due to Staphylococcus aureus pose a major public health threat. In this study, we will define how the “normal” bacterial communities carried on the skin and in the nose may make someone more or less likely to acquire S. aureus. We will also define how topical antimicrobials (often prescribed to prevent S. aureus infection) alter the skin and/or nasal bacterial communities, and discover how these alterations may lead to colonization with harmful or antibiotic-resistant bacteria. This knowledge will help to optimize S. aureus prevention and treatment strategies.